PERSONALITY FACTORS AND PSYCHOPHYSIOLOGICAL RESPONSE TO CHANGING STIMULUS INPUT

The objectives of this project are to investigate relationships among differences in personality, sensory thresholds, reaction time, and autonomic nervous system (ANS) activity in normal humans. Bilateral skin conductance and heart rate have been recorded in sessions in which constant and variable intensity tones and lights are presented, in which auditory and two-flash thresholds (TFT) determined by methods which permit signal detection analyses and in which simple reaction time is measured. Several standardized personality tests were also given. These include scales of sensation-seeking, the Eysenck scales of extraversion, neuroticism, and psychoticism, field dependence and anxiety. In addition comprehensive measures of lateral dominance have been given. A procedure for manipulating ANS arousal experimentally with minimal distracting effects-- a change in posture from supine to standing-- was used to study such problems as the effects of base levels on responsivity, the effects of arousal on performance, and the effects of personality variables on this relationship. Tests of the relationships between laterality in skin conductance variables and behavioral laterality will also be done to see if inferences about lateralized brain function can be made from such variables. Recently, personality variables assessed chiefly from the Eysnck scales, including scales of impulsivity, empathy, and venturesomeness have been correlated with ANS activity in normal children and adolescents. The most consistent results are negative correlations between Extraversion and both phasic and tonic electrodermal responsivity to both nonsignal and signal stimuli and to the onset of a task period.